Short Course Versus Standard Course Antifungal Therapy for Pediatric Candidemia: A Multi-Center Randomized Controlled Trial

Invasive candidiasis is the most common invasive fungal disease, and uncomplicated candidemia is the most
common presentation. Randomized controlled trials in adults and a prospective observational study in children
demonstrated primary treatment with an echinocandin antifungal improved outcomes. While these data inform
initial therapy choice, there remains a paucity of data regarding appropriate duration of therapy. Current
guidelines recommend 14 total days of antifungal therapy for candidemia regardless of clinical presentation and
initial response, yet this is based on opinion and not comparative data. Several studies have proven that shorter
durations of antibacterial therapy are safe and effective for the treatment of numerous serious bacterial
infections. However, there has been no comparative study to assess shorter versus standard duration therapy
for any invasive fungal disease. A large proportion of pediatric invasive candidiasis is uncomplicated candidemia
with relatively rapid clinical improvement on primary echinocandin therapy. It is hypothesized that these patients
do not require 14 days of therapy and instead would be effectively treated with a shorter duration. The primary
objective of this randomized controlled trial is to determine whether 7 more days of therapy is necessary after
completing an initial 7days of echinocandin therapy for pediatric candidemia. Subjects initially treated with an
echinocandin showing clinical improvement with blood culture clearance will be randomized at 7 days into one
of two arms: 1) cessation of therapy, or 2) continuation of therapy for 14 total days. This primary aim will include
a novel outcome measure, the desirability of outcome ranking (DOOR), which simultaneously captures benefits
and negative consequences of treatment. We will compare the DOOR outcome in children randomized to receive
7 days of an echinocandin only (short-course) versus 7 days of echinocandin therapy followed by 7 more days
of antifungal therapy (standard-course). We hypothesize that subjects randomized to short-course therapy will
on average have a higher DOOR measure than subjects randomized to standard-course therapy. The secondary
objective will assess utility of a novel biomarker, the T2Candida® assay, to provide supporting evidence for
effectiveness of short course therapy. We previously demonstrated the T2Candida® assay can rapidly diagnose
invasive candidiasis in children. However, there are no data on the utility of a negative biomarker to support
cessation of therapy. Aim 2 will compare the 14-day DOOR measure for subjects with a negative or positive
T2Candida® biomarker at day 7 of therapy within each study group. We hypothesize that a negative T2Candida®
biomarker at day 7 will be associated with a higher DOOR measure at day 14. This study will leverage the
Pediatric Fungal Network (PFN), a multidisciplinary group composed of 37 sites across the US and the only such
group dedicated to pediatric invasive fungal disease. This will be the first randomized controlled trial to define
the optimal duration of therapy for any invasive fungal disease, and the first to explore the utility of a fungal
biomarker to support a shorter course. Results could impact numerous national and international guidelines.

Public health relevance
NARRATIVE Invasive candidiasis is the most common form of invasive fungal disease. Prospective observational and randomized trials in children and adults have confirmed echinocandins as the antifungal of choice for primary treatment of candidemia. However, while 14 days of therapy is recommended, the optimal duration of therapy for candidemia remains unknown. The primary objective of the proposed randomized trial is to determine if 7 days of therapy is comparable to 14 days for for pediatric uncomplicated candidemia and if a molecular biomarker can provide supportive data for short course therapy.